Stress adaptations in endocannabinoid signaling in the amygdala

Psychosocial stress is a major risk factor for the precipitation and exacerbation of mental illness in susceptible individuals. Understanding the neuroadaptations induced by chronic stress could afford new opportunities for therapeutic intervention for stress-related psychiatric disorders. The candidate has shown that levels of the endocannabinoid 2-arachidonoylglycerol (2-AG) exhibit a progressive increase in response to repeated stress exposure in limbic brain regions including the amygdala, and that this increase contributes stress-response habituation. In aim 1 of this proposal the candidate will determine the temporal dynamics of the 2-AG response to stress and the molecular mechanisms subserving these effects. The candidate will test the hypothesis that the stress hormone corticosterone is required for the adaptations in endogenous cannabinoid signaling to occur in response to repeated stress exposure. Although stress increases 2-AG in the amygdala, it is not known if this increase is associated with enhanced endocannabinoid-mediated synaptic signaling. In aim 2 the candidate will test the hypothesis that this stress-induced increase in 2-AG in the amygdala is associated with enhanced capacity of amygdala neurons to participate in endocannabinoid-mediated synaptic signaling. Finally, in aim 3, the candidate will test the hypothesis that stress-induced increases in 2-AG levels contribute to the behavioral dysregulation induced by chronic stress. Elucidating the stress-induced adaptations in endocannabinoids signaling could provide novel molecular targets for drug development for the treatment of affective disorders.

Public health relevance
PROJECT NARRATIVE: Psychosocial stress is major risk factor for development and exacerbation of many forms of metal illness including mood disorders, anxiety disorder, schizophrenia, and substance dependence. Understanding the brain's adaptive response to stress could uncover novel therapeutic approaches to treat these disorders. Determining the adaptations in the endogenous cannabinoid system in response to stress could provide a novel array of endocannabinoid-based molecular targets for drug discovery for the treatment and prevention of a broad spectrum of mental illnesses affected by psychosocial stress. __SpecificAimsTextDelimiter__ I. SPECIFIC AIMS. Psychological and physical stressors exacerbate pre-existing mental illness, and can precipitate illness in genetically susceptible individuals [1,2]. Stress causes adaptations in brain structure and function aimed at maintaining homeostasis in the face of adverse psychological and physical conditions [3-5]. However, if chronic and unchecked, these adaptations can lead to pathological states of functioning and take the form of mental illness [3]. Understanding the adaptations that occur in response to chronic stress could have broad implications for understanding the pathophysiology of mental illness [6]. Enhanced understanding of stress-induced neuronal adaptations could also uncover novel therapeutic targets for prevention and treatment of mental illnesses affected by chronic stress. Over the past decade a novel class of neuromodulatory lipids, including N-arachidonylethanolamine (anandamide) and 2-arachidonoylglycerol (2-AG), that activates neuronal cannabinoid receptors has been the focus of intense research in neuroscience [7]. These molecules are arachidonic acid derivatives produced by neurons and glia. These compounds act at the same site as the active constituent of cannabis sativa, 9- tetrahydrocannabinol (THC), and are termed endogenous cannabinoids (endocannabinoids [eCBs]; [8]). Production of eCBs is driven by calcium influx secondary to strong neuronal depolarization or burst firing, and activation of some Gq-coupled neurotransmitter receptors and glucocorticoid receptors [7]. eCBs are important retrograde modulators of synaptic signaling at central synapses [9]. Augmentation of anandamide signaling has anxiolytic and antidepressant effects in rodents [10], however, little is known regarding the effects of the eCB 2-AG on anxiety and depressive behaviors. We have begun to study the role of the eCB 2-AG in the brain's response to repeated homotypic stress, a widely used animal model of depression [11]. Our data indicate that a repeated restraint stress increases 2-AG in the amygdala, a key brain region subserving stress- responses and anxiety behaviors. This effect shows a sensitization, as the magnitude of the increase becomes progressively larger with increasing number of stress exposures [12]. Importantly, our preliminary data indicate repeated stress is associated with enhanced 2-AG-mediated synaptic signaling in the basolateral amygdala (BLA) ex vivo. Taken together, these data indicate that chronic stress increases the capacity for 2-AG- mediated eCB signaling in the BLA. Our initial behavioral data indicate that stress-induced increases in eCB signaling contribute to the habituation of active coping responses to stress, suggesting increases in eCB signaling play a significant role in the behavioral adaptations to repeated stress. We will test the overriding hypothesis that repeated homotypic stress induces an enhanced capacity for 2-AG mobilization in response to neuronal activation, resulting in enhanced endocannabinoid/CB1 receptor modulation of synaptic signaling in the BLA. Furthermore, we will test the hypothesis that 2-AG signaling contributes to the anxious/depressive phenotype induced by repeated stress. AIM 1: Characterization of restraint stress-induced modulation of 2-AG metabolism in the BLA. Repeated restraint stress increases 2-AG in the amygdala, but neither the temporal dynamics, effects on the 2- AG metabolome, nor the mechanisms subserving these effects are known. We will utilize a novel mass spectrometry-based analytical technique and western blot analysis to address these open questions. We anticipate that repeated restraint will alter the expression levels of one or more proteins involved in the metabolism of 2-AG in a manner that confers BLA neurons with an enhanced ability to elevate 2-AG levels in response to subsequent stress exposure. These data could elucidate novel regulatory mechanisms of 2-AG signaling by repeated stress. AIM 2: To test the hypothesis that repeated restraint stress enhances 2-AG-mediated synaptic signaling in the BLA. Although repeated restraint stress increases 2-AG in the amygdala, the degree to which this increase is functionally significant is unknown. We will utilize whole-cell electrophysiology to determine the effects of repeat restraint stress on 2-AG-mediated synaptic signaling at inhibitory synapses in the BLA. We anticipate that 2-AG-mediated synaptic signaling will be enhanced by repeated restraint stress exposure. These data would support a functional role for stress-induced increases in 2-AG in the modulation of inhibitory synapses in the BLA. AIM 3: To test the hypothesis that stress-induced increases in 2-AG signaling contribute to stress- induced anxious/depressive behaviors. Stress-induced increases in eCB signaling contribute to the habituation of active coping responses to restraint stress [11], however, the contribution of 2-AG to the anxious/depressive phenotype induced by repeated stress is not known. We will use pharmacological manipulations of 2-AG signaling in vivo to determine the role of 2-AG in the anxious and depressive phenotype induced by repeated stress. These data would confirm that stress-induced elevations in 2-AG modulate behavioral responses to stress. Completion of these studies could uncover novel eCB-based molecular targets for the treatment of stress-related neuropsychiatric disorders.